Mentoring in prevention of hospital-acquired infections and antibiotic resistance

Despite technological advances and improved care delivery, antibiotic resistance and healthcare associated
infections continue to plague our health system. The applicant, Dr. Aaron Milstone, is a Pediatric Infectious
Diseases Physician and Epidemiologist who had focused his career on the prevention of antibiotic resistance
and healthcare-associated infections. This K24 application builds on his career goals of translating laboratory
and epidemiologic observations into patient- and population-level interventions and will prepare him and his
trainees to identify, develop, and test new strategies to prevent infections and antibiotic resistance. The
specific research aims are to: 1) identify risk factors for and develop a predictive model of carbapenem-
resistant organism colonization and transmission in hospitalized patients, 2) identify bacterial communities,
bacterial genes, and patient clinical characteristics associated with resistance to S. aureus nasal colonization
in hospitalized neonates at risk for S. aureus acquisition from parents with known S. aureus colonization, and
3) determine whether bacterial culture stewardship reduces antibiotic use and resistance. The proposed
projects will build on existing funded projects and collaborations in microbiome, genomics, and implementation
science, expand the Dr. Milstone's knowledge in these areas, and make him a more effective PI and patient
oriented research mentor.

Public health relevance
Antibiotic resistance and healthcare-associated infections are major threats to human health and are a top public health priority. This proposal will support mentoring of the next generation of investigators who will advance the science of infection prevention and protect vulnerable populations from the impact of emerging antibiotic resistance.